Establishing the PhenX Toolkit as a Biomedical Knowledgebase

PROJECT SUMMARY/ABSTRACT
The goal of PhenX (consensus measures for Phenotypes and eXposures) is to provide investigators with
standard measurement protocols (e.g., questionnaires, bioassays, physical measurements) to improve the
quality and consistency of data collection and increase the impact of individual studies. Over time, this
common currency will enable investigators to more easily combine studies to increase statistical power and
compare studies to validate findings. Enabling analysis of shared data should lead to a better understanding
of the etiology, progression, and treatment of human disease, ultimately leading to improvements in patient
care, health outcomes and quality of life. To this end, PhenX has established a freely available, Web-based
catalog (https://www.phenxtoolkit.org/) of measurement protocols intended for use in genomic, clinical,
translational, and epidemiological research with human participants. The PhenX Toolkit content and
features are driven by the scientific community. The PhenX Steering Committee (SC) provides overarching
guidance and each measurement protocol in the PhenX Toolkit is selected by a Working Group (WG) of
experts using a consensus-based process that relies on input from the scientific community. Initially
released in 2009, the PhenX Toolkit currently includes 874 protocols addressing human phenotypes and
exposures. In the next 5 years, PhenX will expand the breadth and depth of the Toolkit, increase utility, and
strive to increase awareness of the resource. The Specific Aims are to (1) review, update, and expand
PhenX Toolkit content; (2) leverage biomedical standards to increase scientific impact of PhenX Toolkit;
and (3) raise awareness and increase adoption of the PhenX Toolkit. This research plan will establish the
PhenX Toolkit as a sustainable knowledgebase that organizes, accumulates, and annotates standard
protocols and links them to relevant resources and data. This plan, which reflects a multipronged approach,
will ensure that the value and impact of the PhenX Toolkit will continue to increase over time.

Public health relevance
PROJECT NARRATIVE The proposed 5-year research plan focuses on ensuring that the PhenX Toolkit continues to meet the evolving needs of the genomics, bioinformatics, and biomedical research communities. This effort will raise awareness of the Toolkit as a valuable resource and also attract additional users to the Toolkit. Widespread adoption of PhenX measures will facilitate cross-study analysis and thus increase the scientific impact of individual studies.